Neurocognitive Abnormalities in Stimulant Abuse among High-Risk Women

Project Abstract
There continues to be great interest and public/health/relevance with regard to understanding the neurobiological
systems that underlie the comorbidity of substance use disorders and other psychiatric conditions. In a previous
R01 award, we focused our efforts upon characterizing the neural circuitry underlying moral decision making in
incarcerated men with varying levels of two frequently co-occurring conditions: stimulant abuse and psychopathy.
Here we propose to extend this work to incarcerated women, examine longitudinal outcomes, and apply stateof-the-art network analyses for predictive models. Studies published by our research team have demonstrated
sex differences in the degree and expression of psychopathic traits, patterns of stimulant abuse, and moral
decision-making. However, the neural circuitry that underlies these sex differences is not well understood. We
have also identified substantial sex differences in regional gray matter volume and density in our extant samples.
Collectively, sex differences in pathophysiology could have significant implications for treatment strategies and
differential biomarkers of treatment prediction and outcome in men and women. We will implement the research
strategy with a large incarcerated population by deploying a unique mobile MRI scanner to the regional women’s
prison. Participants will be stratified by their level of lifetime stimulant (cocaine, amphetamine) use severity and
psychopathic traits (high, medium, low) and will undergo anatomical and functional MRI scanning while
completing multi-modal (i.e., linguistic and picture) decision-making tasks. We will also examine functional
network and dynamic network connectivity in women using a new multiband EPI pulse sequence, and collect
longitudinal outcomes after release to the community and test behavioral and neuropredictive models of relapse
and future antisocial behavior. This work is expected to generate a large, robust dataset that characterizes the
overlapping and unique aspects of neural circuitry underlying stimulant use and psychopathy in females. The
proposed research is in line with recent priorities emphasized by NIDA for projects aimed at examining gender
differences, and effects specific to females, to improve our understanding of the nature and etiology of drug
abuse.

Public health relevance
Project Narrative Substance use disorders and psychopathy are serious and costly mental health issues. Psychopathy is known to be associated with aberrant moral decision making and there is considerable interest in determining whether substance use disorders lead to impairments in these same cognitive processes. Recent large-scale research initiatives in forensic settings by our research team have begun to identify substance abuse and psychopathy- related disruption in the neural mechanisms involved in moral decision-making processes, and associations between these neural networks and future relapse and antisocial behavior. Here we extend our prior work (with incarcerated men) to examine these issues among incarcerated women in order to better understand sex differences. This project addresses the overall lack of neurocognitive research in criminal offenders with substance use disorders, thereby focusing on a major public health issue in an underserved and understudied population.